Bioinformatics Module

PROJECT SUMMARY - BIOINFORMATICS
The Wilmer Eye Institute and Hopkins research community have many research
faculty members who conduct basic research projects that require bioinformatics
support. A number of these investigators are working together on disease-
oriented collaborative projects that are informatics intensive. This is partly
because the next generation sequencing is becoming a routine and affordable
technique in the laboratories. The bioinformatics core has been providing
bioinformatics services to many research labs at Hopkins University Medical
School. In this funding cycle, we plan to continue to perform bioinformatics
analysis for the projects initiated by the researchers at Johns Hopkins, provide
educational bioinformatics course for PIs, postdocs and students, and support
the grant applications for the researchers. One new direction we plan to pursue is
single cell data analysis, since more and more labs at Hopkins are starting to
employ single cell sequencing for their projects. We will also provide
bioinformatics seminar series to give tutorials on basic bioinformatics analytic
tools, including single cell data analysis.